Human Induced Pluripotent Stem Cells for Cardiovascular Disease Modeling

PROJECT SUMMARY
While dilated cardiomyopathy (DCM) is one of the most common hereditary heart diseases, we currently lack
effective and targeted treatments. Cardiac fibrosis is an important hallmark of DCM and the presence of
excessive fibrotic tissues can severely hamper heart function. However, limited information exists on how DCM
mutations can induce cardiac fibrosis in familial DCM patients. This study aims to address this significant
knowledge gap using patient-specific human induced pluripotent stem cells (iPSCs) generated from common
DCM patients. In Aim 1, we will differentiate iPSCs into cardiac fibroblasts (iPSC-CFs) and cardiomyocytes
(iPSC-CMs) to study how cardiomyocyte-specific and non-cardiomyocyte-specific mutations can activate cardiac
fibroblasts. In Aim 2, we will examine whether iPSC-CFs induce cardiac dysfunction through secretory factors
and/or direct interaction with cardiomyocytes using a 3D engineered heart tissues (EHT) platform. In Aim 3, we
will identify gene/mutation-specific druggable targets using state-of-the-art CRISPR/dCas9i (inhibitory) and
CRISPR/dCas9a (activating) technologies, and validate these targets in an established DCM mouse model. By
completing this study, we expect to identify fibrosis-inducing DCM mutations, understand how they activate
cardiac fibroblasts, and potentially discover novel druggable mechanism to manage DCM. Collectively, this multi-
PI R01 study has tremendous translational value to aid future precision cardiovascular medicine.

Public health relevance
PROJECT NARRATIVE Dilated cardiomyopathy (DCM) is one of the most common hereditary heart diseases and cardiac fibrosis is a common hallmark. In this study, we will investigate the mechanism of cardiac fibrosis by elucidating cellular crosstalks between cardiac fibroblasts (CFs) and cardiomyocytes (CMs). Coupled with engineered heart tissue (EHT), single cell RNA sequencing (scRNA-seq), state-of-the-art CRISPR/dCas9i and CRISPR/dCas9a genome screening technologies, and DCM mouse model, we aim to uncover the underlying mechanism for cardiac fibrosis development and identify potential therapy to inhibit this process.